Molecular and cellular basis of the renal diseases associated with Alagille Syndrome

Project Summary
The leading cause of end stage renal disease among children under 5 years is congenital abnormalities of the
kidney and urinary tract (CAKUT). Among the several genetic mutations that have been linked to CAKUT are
mutations in Notch signaling pathway genes, JAG1 and NOTCH2. Mutations in these Notch pathway genes are
predicted to reduce the level of Notch signaling activity, and are associated with Alagille Syndrome (ALGS). One
component of ALGS is the variable occurrence of kidney disease including that of small multicystic, dysplastic
kidneys. For instance, a retrospective study determined that 40% of ALGS patients with JAG1 mutations had
some form of kidney disease with dysplastic kidneys with or without cysts occurring in 60% of ALGS patients
with kidney disease. The underlying cellular and molecular mechanisms by which Notch signaling ensures
normal kidney development and maintenance are poorly understood. We know that JAG1 can function as a
ligand to activate NOTCH2, and assume the canonical Notch signaling pathway prevents kidney disease
associated with ALGS. However, mutations in the other canonical Notch signaling pathway components have
not been associated with ALGS. Additionally, the high degree of variability in the manifestation of kidney disease
among ALGS patients is puzzling. In our mouse models the severity of multi-cystic kidney disease increases
with increasing number of Notch1 and Notch2 alleles inactivated in the developing renal epithelium. Here we
propose to determine the Renal Epithelial Notch Signaling Network (RENSN) and perform whole exome
sequencing of ALGS patients to determine if additional variations in RENSN genes in addition to JAG1 and/or
NOTCH2 determine the occurrence of multicystic/dysplastic kidneys in ALGS. Additionally, we will test if
NOTCH2 mutations associated with ALGS alter the orientation of renal epithelial cell division, primary cilia
structure and expression of renal epithelial Notch target genes in different renal epithelial cell cultures. We will
also determine the proximal interacting proteins of wild type versus ALGS associated NOTCH2 variants using
BioID. Additionally, we will apply three strategies to molecularly intervene and prevent the Notch-signaling-
deficient kidney defects. These studies will establish the underlying cellular and molecular mechanisms of kidney
disease associated with ALGS and identify methods to increase Notch signaling specifically in kidney cell types
by determining the molecular interface between Notch signaling and renal epithelial functions.

Public health relevance
Project Narrative These studies have the potential to discover novel epithelial functions of Notch signaling, novel Notch2 and Jag1 interacting proteins, novel genes regulated by Notch signaling, and to identify genetic enhancers/suppressor of JAG1/NOTCH2 mutation dependent kidney disease. We will progress towards finding molecular therapies to improve the health of humans suffering from kidney diseases due to mutations in JAG1 or NOTCH2, like the patients with Alagille Syndrome. In addition, understanding how Notch signaling regulates epithelial cell processes will have a broad impact on understanding Notch signaling as an epithelial tumor suppressor in certain cancers of the kidney, lung, skin, and head and neck.